Role of macrophages in regulating cardiac muscle metabolism

Abstract
Following myocardial infarction, the heart is infiltrated in a precise spatio-temporal manner first by neutrophils
and then by cells of the monocyte-macrophage lineage followed by proliferation of resident fibroblasts and
endothelial cells. Cell-cell cross talk has been recently considered to be an important reparative mechanism
but little is known about how the myocytes themselves engage in such cross talk with non-myocyte cells that
are recruited to the infarcted region. In this proposal, we highlight and investigate an unusual cross talk
between macrophages and cardiac muscle cells in the infarcted heart. We show that cardiac macrophages that
are recruited to the infarcted heart disrupt cardiac muscle metabolism and lead to decreased NAD pools that
play a critical role in cardiac muscle energetics in the infarcted heart. Bone marrow transplantation experiments
performed by us definitively demonstrate that deletion of a NADase on macrophages leads to superior post
infarct heart function and superior cardiac cellular respiration. Finally using monoclonal antibodies targeting
specific NADases on macrophages, we demonstrate that specific targeting of such proteins could serve as
therapeutic strategies for augmenting cardiac muscle energetics and post infarct heart function. We have
created a multi-disciplinary team with expertise in cardiac metabolism, in vivo isotope labeled metabolite
tracing, nucleotide biochemistry and cardiac physiology and comprehensively investigate the cellular,
molecular, and metabolic underpinnings of how bone marrow macrophages regulate cardiac muscle
metabolism and energetics. Our proposal sheds novel insight into the hitherto unappreciated role of how
macrophages regulate cardiac muscle metabolism after heart injury.

Public health relevance
Project Narrative Little is known about how, after a heart attack, the cardiac muscle engages in cellular and molecular cross talk with non-cardiac cells that are recruited to the injury region. Here, we demonstrate that macrophages disrupt cardiac muscle metabolism and investigate molecular and therapeutic strategies to target this cross talk for better cardiac repair.